Biostatistics

PROJECT SUMMARY
The Biostatistics Shared Resource (B-SR) personnel collaborate with SCI members in all seven programs and
support all phases of research, from population and basic sciences through translational studies to clinical trials
and effectiveness research. Capabilities are matched to the needs of SCI members, providing a full range of
biostatistics and study design expertise, from standard techniques to innovative methods developed specifically
to enhance the basic, translational, clinical, and population sciences research efforts. Since the last review and
based on SCI member feedback, the former Biostatistics and Informatics Shared Resource was divided into two
separate resources in 2017 (with EAB and NCI approval): (1) the B-SR and (2) the Biomedical Informatics Shared
Resource (BI-SR). While the two resources continue to have synergy, the change has allowed for a deeper focus
on each SR’s individual missions. The new BI-SR focuses on data organization, curation, management, and
mining that supports the studies. The B-SR strengths are study design and results analysis, with emphasis on
statistically sound methodology. The B-SR also plays a key role in the Protocol Review and Monitoring
Committee and the Clinical Trials Scientific Review Committee. Members of all programs regularly use the B-
SR, with the heaviest use coming from the Population Sciences and Cancer Therapeutics programs. The B-SR
participated in 82 cancer-focused publications in the current funding period, 16 of them in high-impact
publications. The annual budget of the B-SR is $261,592, yet the CCSG request is $149,916. Accordingly, the
B-SR seeks 57% of its support from CCSG funds.